MULTICENTER STUDY OF FILGRASTIM IN TREATMENT OF LATE ONSET NEONATAL SEPSIS

The purpose of this research is to determine whether Filgrastim plus antibiotics is better than antibiotics alone in fighting severe infection in premature infants.